Portable MRI Technology for Neonatal Care

Project Summary/Abstract
Magnetic Resonance Imaging (MRI), especially with diffusion contrast, has been the undisputed standard
of care for the detection and diagnosis of neonatal brain disorders and injuries such as Hypoxic-ischemic
encephalopathy (HIE). However, the nature of these large, expensive, potentially dangerous instruments limits
accessibility and requires that patients be transported to a radiology suite. In the neonatal intensive care unit
(NICU) setting, patient transfer introduces safety concerns, since it requires a full hand-off of patient care
responsibilities and exposes the neonate to stress from transport and acoustic noise. In particular, HIE patients
are often not stable enough to transfer to the scanner for several days after birth. Instead bed-side cranial
imaging is performed with ultrasound, which has a low sensitivity for early abnormalities associated with HIE.
We design a bed-side scanner specifically for the needs of neonatal brain imaging in an NICU. The
proposed scanner will be transported to the bedside in the NICU, prioritizing minimal handling and
manipulation of the infant and enabling true POC diagnostics and monitoring. We significantly reduce the size,
cost, and complexity of conventional MRI hardware by designing for the smaller FOV needed for neonatal
brain imaging and significantly depart from the canonical scanner design. The magnet, field gradients, and RF
coils will be optimized for the smaller imaging volume to maximize image quality. To allow operation outside an
RF shielded room, we propose an EMI mitigation method that retrospectively removes artifacts using external
detectors. As DWI imaging is highly valuable in the HIE patient population, we will develop a RARE DWI
sequence for the unconventional scanner architecture. The new scanner will first be validated with an
anthropomorphic neonatal phantom with realistic tissue properties and then at the MGH Neonatal ICU as an
addition to the standard care of HIE patients. We will determine if the POC MRI offers valuable early
information about the brain condition, which is corroborated in later high-field MRI images obtained when the
baby is stable enough to be transferred to the conventional scanner.

Public health relevance
Project Narrative While MRI is the most effective tool for assessing neonatal brain disease and injury, the size and siting constraints of conventional scanners requires the transfer of patients to a centralized radiology suite for imaging. For unstable newborns with brain injury, there are significant risks associated with this transfer that often preclude MRI imaging. Our goal is to address this with a novel, newborn-sized brain MRI scanner designed for operation at the bedside in neonatal ICUs with minimal patient disturbance.